Minnesota Tissue Mapping Center for Senescent Cells

Project Summary
Senescent cells (SnCs) are known to play a causal role in aging and numerous age-related diseases. However,
they also contribute to wound healing and tissue remodeling. Both physiological and pathological roles are linked
to the secretome of SnCs and their complex interaction with the immune system, which is thought to play an
important role in clearing SnCs. Most of what we have learned about SnCs is derived from mice where it has
been clearly demonstrated that genetic or pharmacologic removal of SnCs in aged or diseased organisms
reduces frailty; improves strength, endurance, and resilience; and attenuates a variety of age-related diseases
including Alzheimer’s. This novel approach of therapeutically targeting a fundamental aging process common to
many diseases – rather than drugging disease-specific perturbations (e.g., low insulin or hypertension) – could
have a tremendous impact on our aging population. However, much needs to be learned about SnCs in humans
to deploy such approaches safely and effectively. This project aims to establish a Tissue Mapping Center at the
University of Minnesota (MN TMC) to contribute to the SenNet Consortium, which intends to build a 4D atlas of
SnCs in multiple human organs with healthy aging. MN TMC proposes to focus on adipose (omental and
subcutaneous), skeletal muscle (Vastus lateralis), liver, and ovarian tissue. This selection is based on MN TMC’s
expertise in the biology, cell biology, and immunology of these organs; in studying SnCs in these organs; and
experience with single cell technologies in these organs. The MN TMC and its Administrative Core will be led by
PIs with complementary expertise in SnCs and computational biology/health informatics. The Biospecimen Core
will be led by the UMN Chairman of Surgery and an accomplished pathologist. The Biological Analysis Core will
be led by an expert in SnC and a molecular pathologist leading spatial genomics at UMN. The Data Analysis
Core will be led by three bioinformaticians with expertise in modeling, single cell, and spatial-omics analysis, and
blending patient electronic health records with -omics data. A unique feature of the proposed MN TMC is that
the entire workflow will be housed within existing infrastructure/cores: from CTSI and BioNet, which manage
human subjects research, tissue procurement, annotation, and distribution/storage, to the genomic/
proteomics/imaging cores, along with the Institute of Health Informatics for data management and multiplexing.
Key personnel include leadership of all of these UMN components. This approach provides unequaled stability
of our analytical pipeline and in-place quality control and assurance mechanisms. A second unique feature of
the proposed MN TMC is our ability to perform spatial transcriptomics and proteomics on formalin-fixed paraffin
embedded biospecimens, which enables analysis of the most stable biospecimens and virtually any archived
material. Overall, the goal of the MN TMC is to make a significant contribution to the 4D atlas of human SnCs,
working closely with NIH and other TMCs to develop and adhere to standards created by the SenNet Consortium.

Public health relevance
Project Narrative The goal of this project is to establish a Tissue Mapping Center to identify and characterize senescent cells in human adipose, skeletal muscle, liver, and ovarian tissues across human lifespan as part of the SenNet Consortium, for which the collective goal is to develop a 4D atlas of human senescent cells.